Title: Pumps for Kids, Infants, and Neonates (PumpKIN) Clinical Trial- Data & Clinical Coordinating Center

Each year, approximately 2000 infants and children less than five years old die as a result of congenital or acquired heart disease. Few options are currently available. Conventional Extracorporeal Membrane Oxygenation (ECMO) only provides support for a few days and the pediatric Berlin Heart Ventricular Assist Device (VAD) is an investigational device in the U.S. and has a substantial number of complications related to the device.